Hormonal Regulation Sertoli Cell Maturation

Project Summary/Abstract
The long-term objective of the proposed research is to further the understanding of mammalian
spermatogenesis at the molecular level. Results from these studies address issues of both human infertility
and contraception. The proposed studies utilize an innovative technique to synchronize spermatogenesis and
isolate subtypes of spermatogonia undergoing development, expanding in numbers and acquiring the
competence to enter meiosis. Isolation of enough of these cells to carry out molecular studies is possible only
because of this innovative technique. Specific spermatogonial subtypes from wild-type and STRA8 knockout
mice will be isolated before and after a retinoic acid pulse. The key focus of the proposed studies will be to
determine retinoic acid responsive transcripts and then relate the genes for these transcripts to chromatin
structure, histone acetylation and enhancer formation. The retinoic acid responsive transcripts will be
determined by RNAseq and the chromatin structure will utilize ATAC chromatin accessibility techniques.
Retinoic acid receptors and H3K27ac modifications will be determined by CHIP-seq. We will determine the
presence of super enhancer sites marked by H3K27ac and examine the epigenetic changes and transcription
factor binding sites in these sites. These studies will provide evidence for the molecular changes required for
the entry into meiosis and lay the ground-work for future studies relating to the molecular causes of infertility.

Public health relevance
Project Narrative: This project will further our understanding of normal spermatogenesis and will provide information relevant to infertility and contraception. In particular, the results will be important in understanding how cells enter meiosis.